Understanding organization of membrane proteins and lipids through lipid vesicle native mass spectrometry

Abstract
In the crowded milieu of the membrane, membrane proteins, with other soluble and membrane-associated
proteins, and lipids form a large number of dynamic and transient protein complexes that in turn govern cellular
physiology. There is mounting evidence that both independent membrane protein-lipid interactions, as well as
bulk biophysical properties of the host membrane often regulate these assemblies. Hence, to understand how
associations between specific membrane proteins help a cell responds to an external stimulus, we need to study
the oligomeric assemblies of the respective proteins directly from the lipid bilayer environment. This brings us to
the primary challenge of studying membrane protein-lipid interactions. The existing tools to study such
interactions lack this critical ability to perform molecular analysis directly from the bilayer environment.
Addressing this challenge, the overarching goal of this project is to develop a novel experimental platform that
enables analysis of MP complexes directly from in vitro lipid bilayers, which can be customized to a target cellular
membrane. To this end, we will combine lipid vesicle technologies with native mass spectrometry (nMS). In Aim
1, taking a set of ten different standard oligomeric membrane proteins we will develop an experimental method
that enables us to determine their oligomeric states directly from a range of lipid vesicles mimicking different
physiological membranes. We will validate and benchmark our results against the known oligomeric masses of
each of these proteins. This will establish the applicability of our platform to detect a wide range of membrane
proteins from a variety of lipid bilayer environments. In Aim 2, we will develop an experimental strategy that
enables us to directly determine the specifically bound lipid binds and where do they bind. To this end, we will
combine nMS with HPLC MS/MS analysis based lipidomics to determine the identity of the lipds. In parallel, in
collaboration with Thermo Fisher Scientific, we will combine ECD fragmentation with lipid vesicle nMS platform
to determine the site of lipid binding. Together, upon successful completion, these two Aims will provide an
arsenal of new technologies to study the oligomeric organization of membrane proteins and lipids directly from
a physiologically relevant lipid bilayer. In Aim 3, we will apply this to a complex biological system to address an
outstanding question in neurobiology; how neurotransmitter filled synaptic vesicles attain their ultrafast speed of
fusion. To this end, we will specifically target the role of synaptophysin, a synaptic vesicle membrane protein
which has been linked to various neurological disorders. The experiment proposed can bring out critical
mechanist and structural insight to understand neuronal signal transduction and related disease-specific
impairments. In the long run, impairment of associations between membrane proteins has been linked to several
pathophysiological conditions ranging from neurodegeneration to cancer. We are confident that the proposed
platform will have a transformative role in studying a wide range of biological processes and associated disease
states.

Public health relevance
PROJECT NARRATIVE Higher order organization of membrane proteins and lipids is pivotal to various cellular signaling pathways. Combining lipid vesicle technology with native mass spectrometry, the project aims to develop a novel experimental platform that can provide a quantitative molecular view of organization of membrane proteins and lipids in the bilayer. With membrane proteins being targets of more than 60% marketed drugs, the transformative potential of this approach lies in its broad impact in understanding various membrane associated pathological states.